Genetic Movement Disorders: Etiologies and Pathogeneses

This application proposes to identify molecular etiologies of heritable movement disorders and elucidate effects
of pathogenic variants as important steps towards improving diagnoses and development of targeted
therapies. The categories of disease studied in this project, including Parkinson’s disease (PD) and related
syndromes, ataxias, spastic paraplegias, and choreiform or dystonic disorders, are all genetically
heterogeneous. We have identified the underlying genes for multiple movement disorders, some of which are a
focus in this proposal, and initiated studies on their pathogeneses. Many more contributing genes remain to be
discovered. We propose to 1) continue to ascertain and characterize individuals and families with genetically
unattributed movement disorders; 2) use state-of-art gene mapping and next-generation sequencing
technologies to discover new genes for movement disorders; and 3) investigate pathogenic mechanisms of
variants using patient tissues, patient-derived stem cell models, and Drosophila models. The proposal builds
on established synergistic collaborations and multifaceted clinical, pathological, basic science, and
translational expertise of the Investigators and Collaborators. It also leverages the invaluable resources of two
large collections of samples ascertained, extensively characterized, and extended over 30 years
(Neurogenetics and PD repositories).
Our approach to disease gene identification combines traditional linkage or identity-by-descent (IBD)
analysis to identify genomic regions shared by all affected family members, together with exome or genome
sequencing and copy number variation (CNV) analysis to identify variants in the linkage/IBD region shared by
affected relatives. Advances in statistical genetics and use of denser marker panels make it possible to
perform such studies in smaller families and more powerful bioinformatics tools offer a stepwise filtering
approach to prioritize likely pathogenic variants for further study. Cosegregation of a variant with disease in
single families and identification of mutations in the same gene in other families and large publicly available
datasets of sporadic cases with the same disorder provide validation that the gene is responsible for the
disease. Disease pathogenesis can then be investigated through mechanistic studies. This approach has led
to our documented record of consistent productivity in parsing genetic neurologic disorders.
For functional studies, we focus on the RAB39B α-synucleinopathy, the ATP6AP2 tauopathy, and SAMD9L
ataxia, pancytopenia and autoimmunity syndrome, three disorders whose causative genes we discovered, and
GBA, which is the strongest known genetic risk factor for idiopathic PD. These four genes participate in
endolysosomal trafficking and autophagy, pathways frequently implicated in PD and other neurodegenerative
disorders. By analysis of gene expression in human autopsy brain samples, we will identify vulnerable cell
types and characterize region-specific changes that drive pathology. Neural and glial cells reprogrammed from
induced pluripotent stem cells (iPSC) of patients will be used to investigate effects of pathogenic variants in
each of these genes, such as a connection between deficiency in ATP6AP2/V-ATPase function, impaired
autophagy, and turnover of aggregation-prone tau protein. Autophagy will be pharmacologically induced to
explore mitigation of tau pathology and improve neuronal survival. Drosophila and iPSC models will be used to
investigate how RAB39B and ATP6AP2 proteins interact with GBA and how pathogenic variants in RAB39B,
ATP6AP2, and SAMD9L influence endolysosomal trafficking.
Beyond the implication of gene discovery for patients who suffer from a particular disorder, each new gene
contributes to our understanding of the complex protein-protein interactions involved in neurodegeneration.
Furthermore, from their biochemical pathways and protein complexes each new gene can uncover additional
candidate genes for the disorders that can also be considered as targets for intervention.

Public health relevance
The goals of this proposal are to identify genes responsible for neurologic disorders that affect movement, including ataxias, parkinsonian disorders, hereditary spastic paraplegias, choreas and dystonias, and decifer the steps that lead from the altered genes to disease. Genetic diseases of the nervous system are relatively common in the Veteran population and the diseases studied in this research project are directly relevant to Veterans’ health. These disorders, and especially parkinsonian disorders and ataxia, disproportionately affect the aging Veteran population. By itself Parkinson's disease affects approximately one million individuals in the United States at an estimated annual cost of $52 billion. Knowledge gained from studies on the biologic causes of the inherited forms of diseases will also increase understanding of more common neurologic disorders and accelerate improvement in diagnosis, management, and treatment of these and related conditions. Therefore, a better understanding of genetic diseases is pertinent to the long-term VHA mission.